Cancer Center Support Grant P30

The purpose of this 12-month study, “Impact of COVID-19 on cancer-related behaviors among nonmetropolitan and minorities in inland northern California: Seeking mitigation strategies? is to measure the impact of COVID-19 on cancer-related behaviors among 1,000 adult respondents and to explore whether telemedicine could be a mitigating factor. These respondents will intentionally over-represent non-metropolitan residents, African Americans, Native Americans, and populations who have Limited English Proficiency. Briefly, the aims are to [1] finalize IRB-approved instruments to measure the impact of COVID-19 on non-metropolitan and minority residents; [2] conduct data collection from these vulnerable populations in the UCDCCC catchment area; [3] disseminate findings to affected populations and to the NCI and professional audiences with the intent to apply insights to mitigation strategies. This Study will utilize qualitative data collection methods, e.g., mail, phone, FaceTime or its Android counterparts, and in-person to characterize responses from non-metropolitan residents, Native Americans, and populations who have limited English proficiency and qualitative research methods (key informant interviews and focus groups) to compile and develop responses from African Americans so that a patient-centered, telemedicine approach could be enhanced. These different methods reflect the premise that “one size does not fit all” and will facilitate the outreach strategies and opportunities in place. Successful achievements of these Aims will result in data that are not only aggregated for the full sample but also dis-aggregated by group (e.g., Native Americans) so that potential solutions might also be customized and shared with collaborators which include Feather River Tribal Health, Northern Valley Indian Health, bilingual/bicultural workers, and UC Davis Comprehensive Cancer Center.

Public health relevance
PARENT NARRATIVE Cancer and its effects are an ever-increasing problem at the population and individual levels. The UC Davis Comprehensive Cancer Center's research is aimed at reducing this burden through cancer prevention, early detection, and treatment that is truly precision and personalized. Unique research strategies include the use of patient-derived xenografts, canine clinical trials, and state-of-the-art imaging, all of which is focused on translating discoveries into innovative clinical trials that ultimately improve the lives of patients and families with cancer. PROJECT NARRATIVE COVID-19 has disproportionately affected minorities, exacerbating risks that existed even prior to the current pandemic. This Study is intended to over-represent the inclusion of minorities, residents residing in non- metropolitan areas, and populations who have Limited English proficiency and to assess the impact of COVID- 19 and the potential role of telemedicine to overcome current barriers.